Admin Core

ABSTRACT
The Core component of the proposed renewal of the “Environmental Approaches to Prevention” Research
Center Grant at the Prevention Research Center (PRC) will perform organizing and administrative functions for
the entire center, supporting the infrastructure critical to the goals and aims of PRC for the period from
December 1, 2022 through November 30, 2027. The Core has coordinating responsibility over all Center Grant
research components, as well as other funded research projects not a part of the Center Grant. Ensuring and
maintaining scientific standards and raising public awareness are primary functions of the Core. Core
responsibilities are both internal (supporting Center Grant and PRC) and external (supporting alcohol
prevention in general).
Major internal functions of the Core specifically related to the Center Grant include: Executive Function,
Administrative Support, Computer/ Statistical Support, and the Research Reference function. The Core will
support administrative time of the Principal Investigator (Dr. Mallie J. Paschall), while the Associate Director
(Dr. Paul J. Gruenewald) will provide administrative time as needed at no cost. The Core will also support two
policy analysts (Dr. Sue Thomas and Mr. Ryan Treffers) and two post-doctoral fellows who will be involved in
multiple research components of the Center. The Core will also provide financial support for meetings of the
Scientific Advisory Council. PRC and its parent organization, Pacific Institute for Research and Evaluation,
provide indirect support for information technology services, facilities management, and recruitment of
personnel, and computer/statistical support functions: word processing, graphic design capability, and
additional data management. The Research Reference function includes maintenance of the alcohol
prevention library.
Alcohol prevention is multi-disciplinary, so the Center cannot function in isolation. PRC staff are involved in
a range of activities designed to create scientific bases for public discussions about alcohol issues and to
contribute to awareness and rational public debate. Therefore, the major external functions of the Core are to
support participation in scientific and professional meetings; conference sponsorship; consultation,
participation in advisory groups, expert panels or direct technical assistance; providing testimony; research
review; editorial review; professional associations; and training.